Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core will provide the organizational base for all UAB ADRC activities. To support
accomplishing the ADRC’s scientific goals of addressing Deep South disparities in dementia, we propose the
following Administrative Core aims: to provide sound leadership, strategic planning, organizational structure,
and coordination of efforts for ADRC operations; to ensure adequate resources for ADRC operations by
providing financial management, securing institutional support for Center activities, and promoting ADRD
faculty recruitment; to establish and coordinate meetings of Internal and External Advisory Committees to
provide evaluation, guidance, and support to ADRC leadership; to direct a developmental project funding
program that promotes new investigators and new lines of inquiry related to Deep South disparities in AD; to
foster and enable AD research at UAB by sponsoring seminars, symposia, and interdisciplinary conferences
focusing on the latest developments in the field; to promote ADRC scientific interactions and sharing of Center
resources with national Alzheimer’s disease research initiatives, including NACC, NCRAD, SCAN, and
NIAGADS; to communicate the ADRC’s progress and activities to our community; and to assure compliance
with NIH policies.